Cell polarity, asymmetric cell division and differentiation in plants.

PROJECT SUMMARY
Generating diverse cell types from a limited number of progenitor cells in development is a significant
challenge in multicellular organisms. Through asymmetric cell division (ACD), progenitor cells divide to renew
themselves and create new cell types. A key process of ACD is the polarization of progenitor cells. Our
research aims to elucidate design principles that govern cell polarization, divisional asymmetry, and the
coordination of cell division and cell-fate determination in plant ACD.
Stomata are microscopic pores in a plant's epidermis. In the model plant Arabidopsis, stomatal development
and patterning provide an excellent platform for studying the molecular mechanisms underlying cell polarity-
driven ACD in plants. The PI identified BASL (Breaking of Asymmetry in the Stomatal Lineages) as the first
intrinsic polarity protein in Arabidopsis that controls stomatal ACD. BASL functions as a paralog of the
conserved PAR proteins in metazoans. Our research, supported by the NIH since 2014, has made significant
contributions to the current understanding of the molecular mechanisms underlying stomatal ACD. Specifically,
we revealed that BASL functions as a scaffold protein that dynamically assembles specific signaling
components required for each step of stomatal ACD. Before ACD, the BIN2 GSK3 (Glycogen synthase
kinase)-like kinases are polarized to maintain a high cell-division potential. After ACD, a YODA MAPK
(Mitogen-activated Protein Kinase) signaling cascade associated with the polarity module promotes cell-fate
differentiation. Furthermore, we identified the BSL1 (bri1 Suppressor 1-like 1) phosphatase that, upon mitosis,
becomes polarized to dissociate BIN2 while activating YODA at the plasma membrane. Thus, the BSL1
molecular switch enables the transition from cell division to cell-fate differentiation during stomatal ACD.
Additionally, our group has determined that polarization of the peripheral membrane protein BASL requires
vesicle trafficking regulated by the PRAF (PH, RCC1, and FYVE) endosomal proteins. PRAFs interact with
GNOM, an activator of Arf GTPases that plays pivotal roles in endocytic recycling in plants. The discoveries of
BSL1 and PRAF represent major milestones in our recent research and offer profound insights into the current
understanding of molecular mechanisms underlying cell polarization and plant ACD.
In the next five years, by employing a comprehensive approach combining genetics, biochemistry, advanced
cell biology, and proteomics/phosphoproteomics, we aim to (1) understand how regulators of membrane
trafficking control targeted vesicle delivery to establish the polarity domain at the plasma membrane, and (2)
determine how cell-cycle regulation coordinates with the dynamic assembly of polarity proteins in stomatal
ACD. Both directions emerge from our recent discoveries and represent significant areas of inquiry. In addition,
we will implement and optimize the usage of TurboID and its variants to enable the spatial and temporal
precision of proximity labeling in living plant cells.

Public health relevance
PROJECTIVE NARRATIVE Asymmetric cell division (ACD) generates diverse cell types and is universally required for development and morphogenesis in multicellular organisms. One fundamental mechanism that controls ACD is cell polarization, which involves the asymmetric distribution of molecules, structures, and functions within a cell. This project aims to establish the molecular and cellular paradigms governing cell polarization, cell division, and cell-fate differentiation during stomatal ACD in Arabidopsis, a system highly amenable to genetic analysis and cell biological examination.